Therapeutic targeting of master regulators in non-canonical AR driven advanced lethal prostate cancers

PROJECT SUMMARY (ABSTRACT)
Androgen receptor (AR) targeted therapies such as abiraterone, enzalutamide, apalutamide, and darolutamide are effective
treatments for patients with advanced castrate-resistant prostate cancer (CRPC). However, resistance to these therapies
represents a significant hurdle in the clinical management of advanced CRPC. Despite initial clinical benefit, most patients
relapse with acquired resistance within a year. An emerging mechanism of acquired resistance to AR-targeted therapy is the
ability of tumor cells to adapt a non-canonical AR activity for survival. Preliminary suggests that increased expression of a
master regulatory transcription factor (TF) cluster (ELF3, JDP2, PBX1, RARA) is associated with the non-canonical AR
activity observed with acquired enzalutamide resistance. Interestingly, expression levels of known AR partners, FOXA1
and HOXB13, were either unaffected or slightly decreased following exposure to enzalutamide in resistant models. AR
chromatin profiling showed a unique binding pattern of AR to novel master regulatory TFs at promoter and enhancer regions
that were absent in the presence of DHT. Preliminary data also suggests a decrease in these master TFs suppresses non-
canonical AR activity and reverses acquired resistance to enzalutamide in preclinical models. The overall objective of this
application is to determine the role of identified master regulatory TFs on non-canonical AR activity associated with
acquired enzalutamide resistance in CRPC and develop optimal therapeutic options that shift cells back to a phenotype that
is clinically manageable and re-sensitized to enzalutamide. Our central hypothesis is that non-canonical AR cistrome
associated with resistance is driven by the recruitment of novel master regulatory transcription factors. Targeting their
vulnerability can re-sensitize resistant cells to enzalutamide. The rationale is that through multimodal molecular
characterization, we can explore therapeutic options that can push back these cancer cells to a canonical AR state sensitive
to enzalutamide. We will test our central hypothesis and accomplish the objective of this application by pursuing the
following specific aims: (i) Multimodal characterization of non-canonical AR activity in patient-derived xenograft models
of advanced disease. (ii) Assess the functional role of identified master regulatory TF on non-canonical AR activity. (iii)
Assess the antitumor activity of candidate combination therapies in multiple PDX models and gather pharmacological and
Toxicology information. Impact: Results from this project will significantly expand our knowledge of the biology of lethal
prostate cancer (PCa) and provide optimal treatment strategies that improve outcomes for men with lethal PCa, reducing
the unequal burden of cancer. Our immediate goal is to leverage information from molecular studies to recognize the subset
of patients where resistance is driven by non-canonical AR activity using multi-omic-based markers. Furthermore, our study
will provide the mechanisms and vulnerabilities of the altered AR cistrome drivers and the implications for drug discovery
and developing optimal therapeutic options for this subset of patients. Our long-term goal is to translate our preclinical
findings into the clinic in the setting of phase I & II clinical trials.

Public health relevance
PROJECT NARRATIVE The androgen receptor (AR) plays a critical role in lethal prostate cancer and despite initial clinical benefit with AR targeted therapy, both intrinsic and more often acquired resistance represents a major challenge. An emerging mechanism of acquired resistance is adaptation to non-canonical AR activity. Thus, in this proposal, we will test the role of identified master regulatory TFs in modulating non-canonical AR activity that aids enzalutamide resistance and determine optimal therapeutic options to overcome resistance using preclinical models.